Postdoctoral Rheumatology Training

[unreadable] DESCRIPTION (provided by applicant): This proposal is the first competitive renewal of a National Research Service Award for Rheumatology Research Training at Northwestern University Feinberg School of Medicine. This request responds to the ongoing, compelling need for Rheumatology research training by providing organized leadership and infrastructure for rigorous mentored research and didactic experiences, all of which have proven to be successful in the current funding period. The program builds on the strengths of current training initiatives in translational, public health and health services research and on the considerable scientific and research training experiences of Rheumatology faculty and collaborators from a wide variety of medical school departments, centers, and institutes. This request fro renewal of the T32 in Rheumatology research comes at a time of substantial and sustained growth in the research enterprise of Feinberg School of Medicine. [unreadable] [unreadable] The long-term, overriding, goal of this training program is to nurture bright, enthusiastic, well-trained, academically-oriented M.D.s and Ph.D.s in their pursuit of a career in Rheumatology investigation, by enabling them to synthesize information about the complex issues associated with conducting scientifically and ethically sound research, and to maximize the likelihood that they will be competitive in seeking subsequent, independent research support. The specific objectives of this training grant are: 1) to provide stipend support for the development of clinical and basic research scientists, who will ultimately be capable of independently performing hypothesis-driven research that address the needs of our target patient population; 2) to protect these research trainees from clinical and other activities which may compete for their time; 3) to sustain an administrative structure that coordinates and provides leadership for our research base as it pertains to our target patient population; 4) to provide both basic and clinical science trainees a rigorous base of classroom study in the disciplines necessary for successfully conducting research relevant to disease etiology, pathogenesis, outcomes, and for the provision of innovative care to patients with arthritis, musculoskeletal, and autoimmune disorders; 5) to further consolidate and enhance, the adult and pediatric, basic and clinical, Rheumatology research training programs at NUFSM; and 6) to continue an ongoing evaluation process for determining whether or not the program is meeting its goals and objectives. [unreadable] [unreadable] [unreadable] [unreadable]